Immune dysregulation in HIV-infected adults with substance abuse and the impact of addiction therapy

? DESCRIPTION (provided by applicant): Challenges in establishing adherence to antiretroviral therapy and other medical interventions contribute to poor outcomes observed among HIV-infected individuals with substance abuse. However, it is also clear that drugs of abuse such as alcohol and opioids have direct interactions with the immune system that accelerate HIV pathogenesis and may also independently contribute to chronic immune dysregulation and activation. Understanding how drugs of abuse, and the medications utilized to manage substance abuse, impact immune function and inflammation is particularly relevant as chronic immune activation is strongly correlated with progression to AIDS, as well as non-HIV related morbidity and mortality. The immunologic consequences, and underlying biologic mechanisms, of alcohol and opioid agonists remain controversial. Recent evidence suggests that interactions between either ethanol or exogenous opioids (such as morphine), and Toll-like receptors (TLR) results in exaggerated neuroinflammatory responses to TLR- ligands. TLR are pattern recognition receptors expressed by adaptive and innate components of the immune system that alert to danger signals. TLR-mediated immune activation by drugs of abuse may lead to chronic and dysregulated immune activation, immune exhaustion, and thereby predispose individuals to consequences of chronic systemic inflammation. Our central hypothesis is that chronic opioid and alcohol use in HIV-infected individuals exaggerates immune dysregulation and chronic inflammation due to altered peripheral TLR responses, and that this dysregulation is reversible through treatment with the opioid antagonist naltrexone. In conjunction with the NIDA CTN-0055 CHOICES pilot study, we have an opportunity to investigate immune activation and function in HIV-infected individuals with opioid and/or alcohol dependency. Notably, CHOICES participants are randomized to receive addiction treatment with a long acting opioid-antagonist, extended- release naltrexone (XR-NTX) versus treatment as usual (TAU) without the use of opioid antagonists, and followed longitudionally. Therefore, we will be able to compare the effects of different treatment strategies for addiction on a variety of immune activation parameters among HIV-infected individuals. Moreover, our inclusion of a comparison group will determine if HIV-infected individuals with substance abuse have significant alterations in immune activation profiles and altered measures of TLR function and expression, as compared to HIV-infected individuals without substance dependency.

Public health relevance
PUBLIC HEALTH RELEVANCE: Individuals with HIV-infection who suffer from drug and/or alcohol dependency, have worse long term health outcomes than HIV-infected individuals without substance abuse. Drugs of abuse such as alcohol and opioid-derivatives (such as heroin), are believed to have detrimental effects on the immune system that are exaggerated in the context of underlying HIV-infection. In this study we will define how several markers of immune function and immune activation differ between HIV-infected individuals with and without substance abuse, and also explore if the therapies used to treat substance abuse in HIV-infected individuals have beneficial impacts on the immune system.